TRAINING PROGRAM IN THE NEUROBIOLOGY OF DRUG ABUSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a training grant in the neurobiology of drug abuse that supports six predoctoral students after their second year when they make a commitment to work in a lab on a drug abuse problem. This funding also supports four postdoctoral fellows. The training may be with any of the approved faculty listed above. This grant has been renewed and we are in the seventh year of funding.